Elacestrant in breast cancer bone metastases

PROJECT SUMMARY
Estrogen receptor (ER) signaling is the main driver of tumorigenesis in ER+ breast cancers by inducing
proliferation and survival through genomic and non-genomic means. Therefore, inhibition of ER signaling has
been a mainstay of treatment for decades. While primary ER+ breast cancer has a relatively good initial
prognosis, ~30% of patients will develop treatment-refractory recurrence or metastasis within their lifetime, with
bone metastasis being twice as likely for patients with hormone receptor positive disease. Despite the frequency
of diagnosis, breast-to-bone metastasis of ER+ breast cancer remains an incurable condition. Treatment
includes administration of ER antagonists like Fulvestrant or aromatase inhibitors, often in combination with a
CDK4/6 inhibitor, which negatively regulates the cell cycle downstream of ER activity. These treatments are
designed to slow progression of disease but are incapable of eliminating metastatic cells. A new endocrine-
targeted therapy, Elacestrant, has been approved by the FDA for the treatment of ER+, ESR1-mutant advanced
or metastatic breast cancer. Interestingly, this compound shows selective agonist activity in the bone
microenvironment, and antagonist activity in cancer cells. Although Elacestrant has been approved by the FDA,
the compound is understudied and is only approved for a fraction of patients. This proposal will utilize in vitro, in
vivo, and ex vivo models of breast-to-bone metastasis of ER+ breast cancer to evaluate the efficacy of
Elacestrant versus the standard of care, as well as dissect the transcriptional landscape which is promoted by
its ER modulation in the treatment setting. Intra-Iliac artery injection of PDX cells in pre-clinical rodent models
will be used to model metastasis and evaluate progression free survival following treatment with Elacestrant as
a mono-agent, in combination with CDK4/6 inhibitors, as well as in novel therapeutic combinations. Because
Elacestrant-induced ER-controlled transcriptional regulation is context dependent, NanoString GeoMx spatial
transcriptomic sequencing, ER ChIP-seq, and rapid immunoprecipitation mass spectrometry of endogenous
proteins (RIME) will be used to begin to determine how one drug can act as an antagonist and agonist in different
contexts. The overarching hypothesis of this proposal is that Elacestrant will extend progression free survival in
pre-clinical models of bone metastasis because it displays context dependent agonist and antagonist activity.
This study will not only lead to a more complete understanding of ER biology in the bone metastatic
microenvironment but will also provide insights which could lead to improved patient outcomes. This project will
also afford me the outstanding training experience to work with multidisciplinary leaders across multiple fields of
biology while I work to complete my PhD training at Virginia Commonwealth University.

Public health relevance
PROJECT NARRATIVE Bone metastasis is an incurable condition, and current standard of care disrupts estrogen signaling in the bone microenvironment leading to bone-related morbidity, which if left untreated may accelerate metastasis. This proposal aims to investigate the use of a novel endocrine therapy called Elacestrant which may lessen destruction of the bone microenvironment while still eliminating metastatic cells, due to context-dependent selective ER agonist/antagonist activity. The proposed study will expand the knowledge of new-generation endocrine therapies in the context of cancer and the cancer microenvironment, as well as yield clinically actionable data which may be rapidly translated to patient care.